Uncovering Mechanisms of Risk-Variant APOL1-modulated Inflammatory Signaling in Macrophages

Project Summary
Chronic kidney disease (CKD), the graduate loss of kidney function, is an incurable condition which affects more
than 37 million individuals in the United States and is costly to manage. In particular, Black Americans face a
higher risk to develop CKD and progress to end stage kidney disease (ESKD) even after accounting for clinical
and socioeconomic factors. Recently, variants in the gene encoding for Apolipoprotein L1 (APOL1) have been
identified as risk factors for focal segmental glomerulosclerosis (FSGS) and HIV-associated nephropathy
(HIVAN) in individuals with recent African ancestry. However, the cell-specific mechanisms that cause disease
are not well understood. In this study we propose to better understand the effect of risk variant APOL1 on
macrophage function and inflammation. Specifically, we hypothesize that risk variant APOL1 hinders the
macrophage's ability to polarize toward an anti-inflammatory phenotype and thus prolongs inflammation in the
kidney after injury. Because APOL1 is found only in humans and new-world primates, we will use induced
pluripotent stem cell (iPSC)-derived macrophages to more accurately model native genomic regulation of
APOL1. To recapitulate the kidney microenvironment and its effects on macrophage activation, we will induce
inflammatory kidney injury in transgenic mice expressing the APOL1 variants. In both iPSC-derived
macrophages and transgenic mouse kidney macrophages we will observe the effects of risk variant APOL1 on
inflammatory signaling, metabolic activity, and mitochondria-mediated autophagy. We will also evaluate the
effect of risk variant APOL1 on anti-inflammatory polarization in macrophages. The goal of this study is to unveil
the mechanisms in risk variant APOL1 macrophages which contribute to kidney disease progression.

Public health relevance
Project Narrative The G1 and G2 variants in the gene encoding Apolipoprotein L1 (APOL1) increase risk for developing focal segmental glomerulosclerosis (FSGS) in people with recent African ancestry, but the exact mechanisms and agents driving the pathology are still being discovered. While the pathologic mechanisms of these variants in glomerular cells are actively being studied, the role of macrophage-mediated inflammation in the development of APOL1 kidney disease is still poorly understood. The research outlined in this proposal will use congenic induced pluripotent stem cell(iPSC)-derived macrophages to elucidate the precise mechanisms that increase macrophage inflammation and subsequent kidney injury, and provide a model to study other genetic drivers of inflammation in macrophages.